Using Machine Learning to Develop Just-in-Time Adaptive Interventions for Smoking Cessation

PROJECT SUMMARY
Mobile technology has enormous potential for delivering highly innovative, dynamic smoking cessation
interventions. Phone sensors, wearable technology, and real time data collection methods such as ecological
momentary assessment (EMA) have made it possible to collect a wealth of environmental and physiological
data such as location, heart rate, and mood. Environmental and situational cues such as craving and proximity
to others smoking are highly predictive of lapse among those trying to quit, suggesting that lapse risk is
characterized by immediate, dynamic influences. Emerging strategies such as just-in-time adaptive
interventions (JITAI), aim to prevent smoking lapse using tailored support delivered via mobile technology in
the moments when it is most needed. Although research has identified antecedents of smoking lapse based on
observations from EMA data, studies have been unable to utilize the full spectrum of contextual and
environmental data available with current technology. Given the importance of dynamic influences on lapse
risk, there is a critical need for strategies that accurately identify moments of highest lapse risk to improve
cessation interventions. Recent research has demonstrated the utility of machine learning to predict individual
behavior. Machine learning is a robust data analytic strategy that can produce highly accurate predictive
models from large datasets and can automatically adapt to new data in real time. The overall objective of this
application is to use supervised machine learning methods to develop an automated algorithm to quantify
smoking lapse risk at the individual level. Specifically, we aim: 1) to apply supervised machine learning
methods to quantify personalized risk of smoking lapse, and 2) to evaluate the feasibility and preliminary
effectiveness of delivering a personalized, just-in-time adaptive intervention driven by machine learning
prediction of smoking lapse risk in real time. The proposed research and training plan will take place at The
University of Oklahoma Health Sciences Center (OUHSC) and the Stephenson Cancer Center (SCC). Training
will focus on increasing knowledge of machine learning methodology, and the conduct and analysis of JITAIs,
which will facilitate completion of the proposed project. Results of the proposed research have the potential to
reduce the amount and frequency of data needed from participants and sensors, enabling the development of
less burdensome interventions. It is expected that completion of these aims will yield preliminary data to inform
an automated, dynamic intervention that fully utilizes the strengths of mobile technology for measuring
individual behavior and environmental context in real time.

Public health relevance
PROJECT NARRATIVE The proposed project will be among the first to use machine learning methods to predict risk of individual smoking lapse in real time. The resulting algorithm will provide a personalized model for each participant that adapts to new data and triggers the delivery of a tailored, precision intervention when it is most needed. If successful, this project and its methodology could be adapted to target other health behaviors such as diet, physical activity, or other substance use disorders.